Regulation of Nuclear Signaling Pathways by the Adenovirus E4-ORF3 Protein

Program Director/Principal Investigator (Last, First, Middle): Hearing, Patrick
Project Summary
The DNA tumor virus adenovirus (Ad) has evolved different mechanisms to target host signaling pathways in
order to optimize the cellular environment during infection. Studies of the Ad replication cycle have revealed
fundamental insights into the regulation of transcription and mRNA processing, protein translation, cell
proliferation, and cell death. Studies of Ad infection also have provided unique insights into innate host
responses to viral infection including the DNA damage response (DDR) and an interferon (IFN) response. This
proposal is based on our studies of how the DNA damage and IFN responses impact the Ad replication cycle
and how Ad counteracts these responses. Both of these pathways critically impact cell life and death
decisions. Studies of Ad infection, both from the cellular and viral point of view, will provide fundamental
insights into essential processes that regulate cell viability and proliferation. The proposal focuses on a highly
conserved Ad regulatory protein E4-ORF3. Mutations in many of the gene products targeted by E4-ORF3 are
associated with human cancer. E4-ORF3 functions to inhibit different cellular effectors involved in the DDR and
IFN responses by sequestering proteins essential for these pathways into nuclear inclusions. During this
process, E4-ORF3 alters the post-translational modification of multiple cellular proteins to induce their
modification by the Small Ubiquitin-like Modifier SUMO. SUMO modifications affects diverse cellular
processes. In the context of Ad infection, E4-ORF3-induced sumoylation targets specific cellular proteins for
degradation by the proteasome. E4-ORF3 also regulates IFN signaling. IFNs repress Ad immediate early gene
expression by inducing transcriptional repressor complexes containing the cell cycle regulator E2F. The IFN–
E2F axis is critical for restriction of Ad gene expression during IFN responses. This likely relates to the known
anti-proliferative properties of IFNs and provides a means to understand the molecular mechanisms of this
process. Specific Aim 1 of this proposal is to investigate the mechanism by which the Ad5 E4-ORF3 protein
induces degradation of cellular substrates. The hypothesis is that the Ad5 E4-ORF3 protein usurps the cellular
sumoylation system to direct poly-sumoylation of cellular proteins to target them for proteasomal degradation.
It is likely that a cellular SUMO-targeted ubiquitin ligase (STUbL) is involved in this process. It is also
hypothesized that Ad uses the enzymatic activity of the AAA+ ATPase p97/VCP to extract cellular proteins
from E4-ORF3 nuclear inclusions to release them for proteasomal degradation. Specific Aim 2 is to investigate
the mechanism of E4-ORF3-mediated sumoylation. E4-ORF3 functions as a SUMO E3 ligase and E4
elongase to catalyze mono- followed by poly-sumoylation of substrates. The hypothesis is that E4-ORF3
functions by recruiting the SUMO machinery and its substrates in proximity of one another by assembling
higher order protein complexes. The Ad5 E4-ORF3 protein is unique in its SUMO E3 and E4 activities. Studies
on E4-ORF3 function will reveal fundamental insights into the mechanisms of host protein sumoylation that
impacts not only the DDR, but also other essential processes such as transcription and DNA replication.
Specific Aim 3 is to investigate the mechanism of inhibition of Ad gene expression and replication by IFN
signaling. IFNα and IFNγ repress Ad5 E1A gene expression via a conserved E2F binding site in the E1A
enhancer region and IFNs induce the binding of repressor E2F complexes to this site. This correlates with the
ability of Ad to establish a persistent infection in the presence of IFNs. IFNs have been used to treat different
malignancies but how these effects are exerted is largely unknown. The hypothesis is that IFN regulation of
cellular proliferation involves the formation of repressor E2F complexes. The regulation of these complexes by
IFN signaling will be investigated. The role of IFNs in the regulation of acute and persistent Ad infections will be
investigated using in vitro and in vivo models.
OMB No. 0925-0001/0002 (Rev. 03/16 Approved Through 10/31/2018) Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Hearing, Patrick Relevance The human virus adenovirus has evolved different mechanisms to modify the host cell in order to optimize the environment for infection. Studies of adenovirus have revealed fundamental insights into the metabolism of cells. Results of studies proposed in this application will provide fundamental insights into essential processes that regulate cell life and death that is at the crux of human cancer development and progression. OMB No. 0925-0001/0002 (Rev. 03/16 Approved Through 10/31/2018) Page Continuation Format Page